NRF2 Activation in Diabetic Wound Healing

PROJECT SUMMARY / ABSTRACT
For patients with diabetes mellitus (DM), the development of chronic wounds is a life-threatening complication
that necessitates over 100,000 lower extremity amputations per year in the U.S. alone. Despite improvements
in the management of DM, the treatment of diabetic wounds remains challenging due to the inherent defects in
wound healing in diabetic vs. normal skin. Underlying vasculopathies, neuropathies, increased inflammation,
and thickened basement membranes due to diabetes predispose the skin to developing non-healing wounds.
Moreover, diabetic skin exhibits increased oxidative stress and decreased expression of nuclear factor erythroid
2–related factor 2 (NRF2), a transcription factor that activates a pathway that protects cells from increased
oxidative stress. Several studies suggest that NRF2 activation could be a relevant target for the management
and prevention of chronic diabetic wounds. The current proposal utilizes novel small molecule NRF2 activators
that exhibit increased specificity of binding and decreased mutagenicity relative to existing compounds,
without sacrificing solubility, potency, or stability. These novel molecules are an innovative and optimal tool to
study the effects of NRF2 activation on diabetic skin. The long-term objective of this work is to develop
topically-applied NRF2-activating drugs for the treatment of human chronic diabetic wounds.
The goals of the current research are to test the ability of highly specific and novel NRF2
activators to improve diabetic wound healing and to understand their mechanisms of action. In
this study, the effects of NRF2 activation on diabetic wound healing will be investigated in db/db mice, a well-
characterized in vivo model system of DM. Aim 1A will determine the effects of this novel class of NRF2
activators on wound healing, including wound closure, oxidative stress, and the quality of tissue restoration.
Aim 1B will employ whole-tissue RNA-sequencing and functional pathway analysis to investigate the effects of
NRF2 activation in diabetic wounds at the transcriptome level. The data will be used to determine which
functional pathways regulated by NRF2 are important to diabetic skin pathology. Aim 2 will examine the
effects of our candidate molecules on macrophages and investigate whether these novel NRF2 activators act by
improving macrophage function in diabetic wound healing. Investigation into the effects of NRF2 activation on
diabetic wound healing may lead to the development of a life-saving, effective, and practical drug for patients
with chronic diabetic wounds.

Public health relevance
PROJECT NARRATIVE In diabetes mellitus, downstream complications such as diabetic neuropathy and vascular damage lead to impaired wound healing, which can result in severe, non-healing ulcers of the lower extremities that may require amputation. Advances in wound healing research have identified some potential mechanisms for this impaired healing, but treatments for diabetic ulcers are lacking in comparison to the overall improvement in the management of diabetes. To that end, this work aims to further understand the inherent deficits in diabetic skin by determining the effects of topically applied novel small molecule NRF2 activators on wound healing and tissue integrity in diabetic wounds and investigating the mechanisms driving their effects.